Computational and Circuit Mechanisms Underlying Rapid Learning

PROJECT SUMMARY/ABSTRACT
The mammalian brain has a remarkable ability to store and retrieve information. Detailed memories can
be formed after as little as one exposure, and those memories can be retained for decades. This ability is
compromised following damage to structures located in the medial temporal lobe, including the hippocampus
and the adjacent cortex. Over the past decade, many studies have highlighted interactions between the
hippocampus and neocortex, in particular, the prefrontal cortex (PFC) and posterior parietal cortex (PPC), as
having an essential role in memory consolidation. However, the circuit mechanisms that support memory
consolidation are not well-understood, particularly in the primate brain. Impaired memory is an important
component of diseases such as Alzheimer's disease, temporal lobe epilepsy, depression, and schizophrenia
that collectively affect over twenty million Americans. Our long-range goal is to contribute to a better
understanding of the neural mechanisms that underlie memory processes, in order to bring us closer to
developing new therapies for these disabled patients. Psychological theories and behavioral studies have
suggested that rapid, single-trial accumulation of information is facilitated by prior knowledge, a cognitive map
or “mental schema” that provides a framework onto which new information can be assimilated. This concept is
relevant for understanding potential hippocampal-neocortical interactions in the service of memory consolidation.
The experiments proposed here will directly examine the neural circuits in the hippocampus, PFC, and PPC that
support schema development and new learning. The overall goal of this U-19 Program is to develop a
comprehensive theory of the circuit mechanisms that support rapid learning. To achieve these goals, we will
make use of a multi-laboratory research framework with an ambitious effort that requires multiple areas of
expertise, exemplified by our team members. Our team effort is organized around four Research Projects, each
supported by Data Science and Administrative Cores. Through parallel projects in monkeys and humans, we will
perform large-scale recordings simultaneously across the hippocampus, PFC and PPC to assess modulations
in cross-regional connectivity during schema development and new association and categorization learning.
Complementary theoretical approaches will integrate large-scale circuit modeling of the human and nonhuman
primate brain based on measured mesoscopic connectivity and training recurrent neural networks to perform
cognitive tasks. We will test the hypothesis that in the course of schema instantiation, a task structure is encoded
in the form of a low-dimensional structure in the space of connection weights, which is reflected in a low-
dimensional subspace of neural dynamics. During new learning, the system benefits from the schema to narrow
weight parameter search, thereby speeding up learning. We hypothesize that this process is observable at the
level of dynamical inter-areal interactions. Taken together, the experiments proposed under this Program will
provide a comprehensive, cross-species investigation of the neural mechanisms of rapid learning.

Public health relevance
Narrative Previously acquired knowledge provides a structure, or schema, that shapes ongoing experience and facilitates the rapid acquisition of new information. A large body of research supports the idea that interactions between the hippocampus and neocortex are critical for rapid learning based on prior knowledge; however, there is a surprising gap in our understanding regarding cortical-hippocampal interactions in the primate brain. Here, in parallel studies in monkeys and humans, we propose to take advantage of newly available large-scale recording techniques to examine hippocampal-neocortical interaction that may underlie both the development of a schema and the use of a schema for rapid learning.